Neurotherapeutics Symposium 2022: Integrating Equity within Translational Research

PROJECT SUMMARY
Life-changing and curative therapies for disabling and fatal neurological conditions are costly and
often inaccessible for patients from underrepresented minority (URM) populations. During trans-
lational research in neurology, much of this inaccessibility begins at the therapy development
phase and grows through the implementation and dissemination phases. There is, therefore, a
critical need to widely educate the neurology workforce on the importance of integrating an equity
focus within translational research in neurology, with the ultimate goal of accelerating the transla-
tion of advances in neurological therapy into improved health outcomes for all patients. As the
first virtual conference dedicated to address this problem, the “Neurotherapeutics Symposium
2022: Integrating Equity within Translational Research”, will achieve the following aims: 1) dis-
seminate knowledge on existing inequities and ongoing efforts to integrate equity within transla-
tional research in neurology, 2) facilitate the integration of an equity focus within ongoing and
future translational research efforts of symposium participants, and 3) assess the extent to which
participants knowledge on existing inequities and ongoing efforts to integrate equity within trans-
lational research in neurology has increased. During online registration, an electronic survey of
10 multiple-choice questions will assess pre-conference knowledge on 1) existing inequities dur-
ing translational research in neurology and 2) ongoing efforts to integrate equity within transla-
tional research in neurology. Registered participants, particularly trainees and early-career inves-
tigators, will be encouraged to submit abstracts to present their research. Abstracts will include
an “equity focus” to emphasize the importance of this topic for the conference. During the sympo-
sium, experts in the field will deliver 10 virtual lectures and will participate in four panels using
stroke, multiple sclerosis and Parkinson’s disease as examples to illustrate the topics of the con-
ference. Three mentoring group sessions and a virtual poster presentation session will facilitate
discussion, development and expansion of the “equity focus” described in submitted abstracts.
Six months after the symposium, the same electronic survey will measure change from pre-con-
ference knowledge. The expected outcomes of this conference is that up to 150 participants will
have increased their knowledge and integrated an equity focus within their ongoing and future
translational research efforts in neurology.

Public health relevance
PROJECT NARRATIVE The “Neurotherapeutics Symposium 2022: Integrating Equity within Translational Research” is the first meeting during which all stakeholders will address health inequities during translational research in neurology. This meeting is relevant to public health and to the mission of the NIH because it will facilitate the integration of equity within ongoing and future translational research efforts in neurology, which will contribute to increased access to life-changing and curative ther- apies for disabling and fatal neurological conditions for all patients.